Achieving Maternal Equity and Transforming Health through Implementation Science and Training (AMETHIST@Penn)

PROJECT SUMMARY (ABSTRACT)
Achieving Maternal Equity and Transforming Health through Implementation Science and Training
(AMETHIST@Penn)
The NIH Implementing a Maternal Health and PRegnancy Outcomes Vision for Everyone (IMPROVE) initiative
aims to reduce maternal mortality, improve pregnancy, perinatal and postpartum care, and to address the factors
that have led to severe disparities in outcomes for marginalized groups. The University of Pennsylvania (Penn)
proposes creating the Achieving Maternal Equity and Transforming Health through Implementation Science and
Training (AMETHIST@Penn) Implementation Science Hub to support IMPROVE Maternal Health Research
Centers of Excellence (CoEs) and other IMPROVE investigators, and to coordinate with NIH Staff Scientists,
Project Staff, and the Data Innovation and Coordinating Hub. AMETHIST@Penn will be led by MPIs Meghan
Lane Fall, MD, MSHP, and Rebecca Hamm, MD, MSCE, who bring complementary and necessary strengths in
implementation science (IS) and maternal health. Dr. Lane-Fall is Executive Director of the Penn Implementation
Science Center at the Leonard Davis Institute of Health Economics (PISCE@LDI). She is an internationally
recognized acute care IS expert with an independent IS research program. She has 8 years of experience as a
collaborator and consultant advising investigators on: selection of IS theories, models, and frameworks, including
those focused on equity; implementation mapping and strategy selection; implementation outcome selection;
data integration across multiple types and sources; and advanced analytic procedures to elucidate change
mechanisms. Dr. Hamm is a maternal fetal medicine specialist who has established herself nationally as a
researcher at the crossroads of obstetrics and IS. Together they will orchestrate the work of AMETHIST@Penn,
leading an interdisciplinary, interprofessional group of more than 45 scientists and community partners. The
AMETHIST@Penn Hub will comprise five Cores, each with two Co-Leads and 2-4 Core Investigators:
1) Administration, Leadership, and Evaluation; 2) Equity, Community and Stakeholder Engagement (with an
Equity Advisory and Oversight Board to advise and hold investigators accountable for incorporating equity into
their research); 3) Design, Methods, and Analysis (including a Consultant Panel with Methods, Equity, and
Clinical subpanels to meet the anticipated consultation and technical assistance needs of the CoEs); 4) Policy,
Dissemination, and Communication (with skills building in messaging and media training); and 5) Training and
Capacity Building (featuring an innovative academic-community partner training program and a comprehensive
mentored research experience for both new and established investigators). In addition to establishing and
administering the Hub, a research aim includes prospective mixed methods research on IS investigators,
community partners, and institutions to characterize predictors of project-based implementation success and
multilevel barriers to and facilitators of the conduct of maternal health IS research. The AMETHIST@Penn hub
will advance public health and maternal health equity by facilitating rigorous implementation research that
centers the needs and perspectives of patients, communities, and health disparity populations.

Public health relevance
PROJECT NARRATIVE Achieving Maternal Equity and Transforming Health through Implementation Science and Training (AMETHIST@Penn) The Achieving Maternal Equity and Transforming Health through Implementation Science and Training (AMETHIST@Penn) Hub will support the vision of the NIH IMPROVE initiative by providing consultation and technical assistance to Maternal Health Research Centers of Excellence and other IMPROVE investigators. The AMETHIST@Penn team will work closely with NIH staff and the Data Innovation and Coordinating Hub/Resource Center and will support equity-focused maternal health implementation research through five Cores: (1) Administration, Leadership, and Evaluation; (2) Equity, Community, and Stakeholder Engagement; (3) Design, Methods, and Analysis; (4) Policy, Dissemination, and Communication; and (5) Training and Capacity Building. AMETHIST@Penn will serve IMPROVE investigators by advising them in engaging diverse and sometimes marginalized communities; guiding the process of implementation research including the selection of theories, models, frameworks, strategies, and outcomes; and accelerating implementation skills development in emerging and established maternal health scientists.